Harvard Translational Research in Aging Training Program

Project Summary:
This application seeks to renew our 15-year old T32 training program in “Translational Research in Aging” at
Hebrew SeniorLife, a geriatric teaching hospital affiliated with Harvard Medical School (HMS) and home of the
Hinda and Arthur Marcus Institute for Aging Research. The program will continue to be directed by Dr. Lewis
Lipsitz, MD, Professor of Medicine, Director of HSL's Marcus Institute, and Chief of the Beth Israel Deaconess
Medical Center (BIDMC) Gerontology Division. Dr. Edward Marcantonio, Professor of Medicine and Section
Chief for Research in the BIDMC Division of General Medicine will be the Associate Director. Both are senior
NIA-funded investigators, highly regarded mentors, and recognized leaders in Gerontology. The specific aims
of our program are: 1) To provide a 2-year mentored training program in basic, patient-oriented, or population-
based aging research for 3 highly qualified, racially and ethnically diverse post-doctoral trainees each year,
and to promote their achievement of successful independent research careers focused on the conduct of
scientific research that will inform the development of interventions to improve the quality of life and well-being
of older adults; and 2) To continuously evaluate our program objectives and the progress of our postdoctoral
trainees, and make continuous quality improvements to ensure that we achieve our goals. During the past 15
years we have trained 43 postdoctoral fellows (9 MDs and 34 PhDs), 33 of whom (77%) now hold academic
positions at major universities. In total they have published 307 papers and won 126 grants as Principal
Investigator or Co-PI. During the current funding period we have filled all of our positions and trained 15
postdoctoral fellows who have published 154 papers and won 10 grants. Five of our 9 graduates so far have
acquired full-time research positions at premier universities or medical centers. The proposed renewal of our
postdoctoral training program includes mentored research experiences, seminars, coursework, interdisciplinary
workshops, intensive instruction in scientific rigor and reproducibility and the responsible conduct of research,
a formal evaluation process, and substantive exposure to a multi-disciplinary faculty in the field of aging. Our
trainees also benefit from our close collaboration with the Boston OAIC, Boston Roybal Center, and Harvard
CTSA (Catalyst), which provide additional research training, pilot grants, and career development support. Our
strong pipeline of talented students and minority recruitment plan help assure that we will train future
generations of translational scientists committed to developing interventions that improve the health and well-
being of older adults.

Public health relevance
Project Narrative: This training program addresses the critical need for new investigators in the field of aging who can help solve the numerous health-related problems that will soon confront our rapidly aging population. The program will prepare a new cadre of academic leaders in geriatric medicine and aging research, who will be equipped with the necessary skills to understand the aging process, study why it often leads to disease, and determine how to prevent the onset of disease and disability in late life. .